Animal Production Core

Alcohol and other substance abuse continue to be enormous public health issues with total
costs in the US approaching a half billion dollars a year. Although there are major attempts at
prevention, a better understanding of the genetic and environmental factors that increase the
risk of alcohol use disorders, the neural circuits that underlie this risk, and the ability to regulate
these circuits therapeutically are all still critically needed. In addressing this critical need, this
Animal Production Core will continue to provide the P and HAD1 rats, along with cHAP mice
that have been selectively bred for high voluntary alcohol, to investigators in the Indiana Alcohol
Research Center (IARC) or on the Indiana University–Purdue University at Indianapolis (IUPUI)
campus. These lines are unusual among rodents due to their excessive alcohol intake, with
cHAP mice, for example, reaching BECs over 250 mg/dl during simple voluntary alcohol access.
We will also maintain colonies of LAP3, along with non-selectively bred Wistar rats and inbred
C57Bl/6J mice for comparison purposes. This Core is the outgrowth of over 30 years of
experience with selective breeding, maintenance of breeding colonies, and solving problems
arising with the logistics and nature of running an operation of this magnitude. We are therefore
uniquely qualified in the coming funding period to continue to provide these animals to
alcoholism and addiction researchers, to coordinate the use of the animals to avoid scientific
overlap, and to manage issues that could affect their phenotype and associated behaviors. The
Animal Production Core will continue to characterize these lines as animal models of addiction
and promote their use in examining the genetic and neurobiological substrates of substance
use, abuse and dependence.